Advanced high-content chemical imaging tools for phenotypic drug screening in 3D culture models

Abstract:
The discovery and development of new pharmaceuticals are hindered by high attrition rates, long development
cycles, and escalating costs. On average, launching a new drug takes 12 years and costs more than $2 billion,
with approximately 90% of clinical drug development failing mainly due to inadequate efficacy and unforeseen
toxicity. Traditional cell cultures and in vivo animal models frequently lack predictive power for assessing efficacy
and toxicity, leading to costly late-stage failures. In response, there has been a paradigm shift towards using
more sophisticated model systems in drug screening, such as 3D culture models and organ-on-a-chip. These
models require sophisticated assays that capture the heterogeneity and dynamic nature of drug response at the
single-cell level and provide insights into mechanisms of action (MOA).
High-resolution chemical imaging, particularly Stimulated Raman Scattering (SRS) microscopy, could potentially
fulfill the role of multiparametric phenotypic imaging in complex 3D models. SRS leverages vibrational bond
information to generate detailed maps of cellular components and compounds without the need for fluorescent
tags that may perturb cellular functions or introduce staining artifacts. My group is at the forefront of applying
SRS microscopy to imaging of small molecules such as drugs. In recent years, we have developed various
techniques and strategies for quantitative SRS imaging of complex samples, applying these techniques to study
single-cell drug uptake and response. These advancements have positioned us uniquely to leverage SRS as a
phenotypic imaging tool in high-content drug screening for both efficacy and toxicity. This project has three
synergistic directions: 1) developing innovative tools for longitudinal, multiparametric phenotypic imaging of
single cells, 2) applying phenotypical imaging tools to drug efficacy screening and mechanism of action prediction
using tumor spheroids and cuboids as model systems, and 3) multiparametric imaging, classification, and
prediction of drug-induced liver injury in physiologically relevant tissue models. Together, these directions will
enable the development and validation of new tools and methods to significantly improve drug efficacy and
toxicity testing. By integrating SRS imaging and machine learning into phenotypic drug discovery workflows, our
project promises to accelerate the selection of promising drug candidates and illuminate the pathways through
which they exert their effects.

Public health relevance
Public Health Relevance/Narrative Developing new drugs is a long and costly process, often taking over a decade and costing billions, with a high rate of failure due to unexpected side effects and lack of effectiveness. Our project uses advanced imaging technology coupled with innovations in machine learning to better predict drug efficacy and toxicity with advanced cell culture models. By improving how we test drugs, this research could lead to accelerated drug discovery with safer medications.